Seminal plasma metabolomic signatures, preconception phthalates and reproductive outcomes.

SUMMARY
Infertility is one of the most common reproductive health disorders affecting 16% of couples in the U.S. Infertility
has been historically treated as a female problem; however, one-half of infertility cases can be attributed partially
or completely to male factors. Phthalates, a class of endocrine disrupting compounds used in plastics and
personal care products, are ubiquitous environmental contaminants resulting in widespread human exposure. In
humans, male phthalate exposure is associated with low sperm quality, poor embryo development and longer
time to pregnancy. Despite major advances in understanding the molecular characteristics of semen,
conventional semen parameter analyses remain the most prevalent diagnostic tool to assess male fertility. Thus,
developing novel biomarkers of male reproductive health and determining how these biomarkers are impacted
by environmental exposures is vital to improve clinical care and reproductive health. Seminal plasma, which
comprises ~90% of semen, contains a diverse composition of metabolites that protects and nourishes sperm
during transit in the male reproductive tract and, subsequently, in the female reproductive tract. These
components have been shown to play important roles in sperm development and function, suggesting that the
seminal plasma is not just a medium for sperm transfer and protection but can also be utilized as a biospecimen
matrix to study spermatogenesis and male infertility. As such, we propose that seminal plasma metabolomics
are key to understanding how male phthalate exposure impacts reproductive health. Our objective is to identify
seminal plasma metabolomic signatures that are associated with paternal phthalate exposure and reproductive
health outcomes, such as fertilization, embryo quality, time-to-pregnancy, and probability of live birth. This
application capitalizes on extant sample and data collection from the Sperm Environmental Epigenetics and
Development Study (SEEDS), an epidemiologic study investigating the link between paternal phthalate exposure
and adverse reproductive health among couples seeking fertility treatment. We also propose a replication aim to
analyze seminal plasma metabolomics from samples collected from the Longitudinal Investigation of Fertility and
the Environment (LIFE) study, a prospective preconception cohort of couples from the general population. We
will conduct the following aims: 1) determine the associations of preconception urinary phthalate metabolite
concentrations with seminal plasma metabolomics in SEEDS; 2) determine the relationships of seminal plasma
metabolites and reproductive outcomes in SEEDS and 3) replicate and further characterize seminal plasma
metabolomic findings in an independent set of participants from the LIFE Study. These results will constitute
major advances in the fields of environmental and reproductive health by improving clinical assessments of male
fertility, and thus, is a critical step toward developing interventions for male infertility.

Public health relevance
NARRATIVE This project investigates the link between paternal phthalate exposure, seminal plasma metabolomics, and reproductive health outcomes. The study has important public health implications by determining potential pathways by which paternal toxicant exposures influence reproductive health. Seminal plasma metabolomic results will constitute major advances in the fields of environmental and reproductive health by improving clinical assessments of male fertility, and thus, is a critical step toward developing interventions to improve male reproductive health.